Task C16: Production and Development of Schistosomiasis Research Reagents

This contract provides for the development of new and refinement of existing animal replacement and non-traditional animal models and may include evaluation of candidate countermeasures.